Visual hallucinations and memory impairment in Parkinson's Disease: The role of hippocampal networks

PROJECT SUMMARY
Parkinson's disease (PD) is diagnosed based on its characteristic motor symptoms of bradykinesia,
rigidity, and tremor. Increasingly, neuropsychiatric symptoms are identified as part of the neurodegenerative
process of PD. Cognitive impairment and psychosis increase as PD advances and are associated with increased
caregiver burden, impaired daily functioning and nursing home placement, dementia, and greater mortality.
Specifically, memory impairment and hallucinations occur in a subset of PD patients and are associated with an
increased risk for dementia and functional impairment. It is well established that the hippocampus is critically
important for memory function and hippocampal dysfunction has been shown to significantly contribute to
memory impairment in numerous human and animal studies. Similarly, it is now recognized that the hippocampus
plays an important role in the etiology of hallucinations across various psychotic disorders. However, the role of
hippocampal networks in the parallel clinical course of memory impairment and hallucinations in PD remains
unclear. The goal of this project is to assess whether hippocampal network dysfunction provides a shared
mechanism for memory impairment and hallucinations in PD and determine whether increased activity in specific
hippocampal subregions predicts greater cognitive and functional decline longitudinally.
The current project aims to achieve these goals using detailed neuropsychological assessment and high-
resolution functional magnetic resonance imaging (fMRI) methods in PD patients with episodic memory
impairment, PD patients with hallucinations, PD patients without episodic memory impairment or hallucinations,
and healthy controls. A targeted fMRI activation task will be employed designed to tax hippocampal subregion
specific functioning. High-resolution resting-state fMRI will be used to assess connectivity changes between
hippocampal and cortical networks. Clinical and cognitive assessments will be repeated at a two-year follow up
to assess longitudinal change and predictive value of these fMRI markers in the progression of cognitive and
functional decline in PD.
Together the proposed studies will provide insight into the role of the hippocampal network in memory
impairment and hallucinations in PD. The results will determine whether dysfunction in hippocampal subregions
is a marker of episodic memory impairment and hallucinations in PD patients and a predictor of increased risk
for future decline in this subset of patients. Finally, if successful, this work would additionally provide a target for
the development of new therapeutic interventions for memory impairment and hallucinations in PD.

Public health relevance
Narrative In addition to the characteristic motor symptoms, patients with Parkinson’s disease (PD) also experience significant neuropsychiatric symptoms. Using detailed behavioral testing and high-resolution brain imaging methods, this project aims to examine brain regions known to play an important role in memory function and hallucinations in participants with PD and shed light on the relationship between changes in these brain regions and the parallel clinical course of memory deficits and hallucinations in PD patients with memory impairment or hallucinations compared to PD patients without memory impairment or hallucinations, and healthy controls. Repeat clinical assessment two years after neuroimaging will determine whether changes on fMRI associated with memory impairment and hallucinations in PD are predictive of future cognitive or functional decline and may be a target for intervention.